PAC1 receptor antagonists as potential treatments for depression and atherosclerosis associated with chronic stress

During this period, a new cell-based assay to examine PAC1 activity in neuroblastoma cells was explored towards high-throughput screening. Molecular modeling studies were performed to identify candidates that bind to PAC1R. The Early Translation Branch (ETB) has maintained over 130 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to dozens of high-throughput screens and a number of medicinal chemistry campaigns to further improve on screening hits, providing our collaborators and the general research community with publications and a variety of promising small molecule probes and leads. In addition, the ETB has worked to advance a number of informatic initiatives to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.